in vitro modeling of IgH-reprogrammed B cells in secondary lymphoid organoids

PROJECT SUMMARY/ABSTRACT
The main goal of this project is to develop and test a cell therapy that supports the development of robust,
boostable, and durable broadly neutralizing antibody (bnAb) responses as a functional cure for HIV. This portion
of the P01 project will focus on optimizing this therapeutic strategy in immune organoids, which are derived from
murine, non-human primate, and human lymphoid tissues and can recapitulate several aspects of in vivo
germinal center responses. Clinical trials have shown that sufficiently high antibody titers can suppress viremia
during withdrawal of conventional antiretroviral treatment. However, achieving durable bnAb responses using
current techniques remains challenging due to low B cell receptor (BCR) precursor frequency. Recent
advancements have demonstrated that murine B cells can be reprogrammed to express HIV bnAbs using gene-
editing technologies, but significant efforts are needed to determine how to guide these cells into germinal center
reactions and subsequent durable memory and long-lived plasma cell phenotypes. Our proposal seeks to
optimize techniques for translating this strategy to non-human primate models and human clinical studies. Our
project will address the lack of animal models that accurately replicate the human HIV-specific immune response
by testing engineered B cells in lymphoid tissue organoid models across murine, non-human primate, and human
systems. By integrating in vitro organoid cultures with in vivo data, we aim to predict and optimize HIV-specific
B cell responses, and ultimately accelerate the translation of our strategy into the clinic. In this project, we will
characterize engineered B cell behavior, identify effective immunogen pairings, and advance the development
of durable and scalable bnAb therapies for HIV. Our work will use protein designs and engineered cells from the
affiliated immunogen and B cell engineering cores. We will also collaborate with the ‘Last Gift’ study to validate
engineered B cell responses in organoids prepared from lymphoid tissues of people living with HIV to assess
preventive vs. therapeutic cell therapy strategies. Successful completion of this project will establish the
predictive value of organoid models for analysis of HIV responses across murine, NHP, and human model
systems, with the long-term goal of accelerating the development of B cell bnAb engineering-based therapies
for HIV. Additionally, the organoid approach will enhance our understanding of B cell biology and immune
response dynamics during HIV antigen stimulation and infection. By developing and refining organoid culture
techniques, we hope to better mimic in vivo responses and provide a valuable tool for future research. This
project not only seeks to advance therapeutic approaches but also develop and test a scalable platform for rapid
optimization of engineered cells and immunogens to develop the targeted adaptive immune response, ultimately
contributing to the broader field of HIV research and treatment.